Assay Guidance Manual

AGM eBook: during this period, national and international viewership of the content has grown substantially with ~780k total accessions in 2024 (compared to ~580k in 2023). In 2025, the AGM eBook saw a remarkable further increase in website traffic with more than 420k accessions in the first half of the year.

AGM Webtools: the AGM Webtools, which include Replicate-Experiment and Control Charting, have been designed and developed as a companion to the AGM eBook. The AGM Webtools generate assay statistics and visualizations for researchers to easily evaluate and document assay repeatability and reproducibility. The purpose of Replicate-Experiment is to validate minor changes to assay protocols, whereas the purpose of Control Charting is to monitor assay performance over time. The AGM Webtools are currently in their final phase of development.

Assay Guidance Workshops: Assay Guidance Workshop for In Silico Drug Discovery. (Oct 23-24, 2024. Virtual): 3,237 live views. This two-day free virtual workshop brought together experts from academia and industry to develop best practices in building accurate, robust, and rigorous artificial intelligence (AI)/machine learning (ML) models to support and guide experimental drug discovery projects. The workshop had 19 presentations, including sessions on data sources, methodology, applications, and emerging trends, and concluded with a discussion and Q&A. More information and recordings are available here: https://ncats.nih.gov/research/research-resources/agm/agm-workshops.

AGM Preclinical Translational Science Webinar Series: our quarterly series has attracted on average 300 attendees per webinar for this fiscal year. Our webinars are always streamed freely and the recordings posted online shortly after. In FY2025, we hosted 4 speakers including a Nobel Laureate.

Research: to determine cross-platform reproducibility of biochemical proximity-based assays in identifying HTS hits, we are comparing screening results from a single PPI across three platforms, and studies are ongoing. For the Nuisance Compound Tool Consortium, the consortium has been established, and discussions are underway regarding the composition of the nuisance library.